Light-Controlled Supramolecular Platinum Complexes for Biomedical Applications

PROJECT SUMMARY
Our goal in this R15 proposal is to investigate the photoreduction of Pt(IV) complexes as a new versatile
approach for NIR-uncaging that can operate both in vitro and in vivo. Photo-uncaging is a technique that
selectively blocks biologically relevant functional groups, enabling external spatiotemporal control with light.
Targeted light-induced cleavage is used to achieve uncaging and release the photolabile protecting group,
providing a means to regulate the amount of the relevant compound released. However, the current limitation of
photolabile protecting groups has largely restricted photo-uncaging technology to the use of UV light. NIR light
(700–1000 nm) can penetrate deeper into biological tissues, making it a promising candidate for biomedical
research and phototherapy. This R15 proposal aims to present a new approach toward overcoming such
drawbacks by inventing novel fluorophore-conjugated Pt(IV) complexes for NIR-uncaging. The central
hypothesis is that photoreduction of Pt(IV) complexes enables NIR-uncaging of bioactive ligands. This
hypothesis is based on our preliminary data: 1). photoinduced electron transfer empowers rapid activation of
Pt(IV) complexes via conjugation with fluorophores. 2). conjugation of the Pt(IV) complex with IR780 (a lipophilic
NIR dye) enables photoreduction upon NIR irradiation. 3). the use of carboplatin as the Pt core generate Pt(IV)
complexes with excellent stability against biological reductants without additional protection. 4). the fluorophores
being used in the scaffold dictate the wavelength of light irradiation from visible to NIR. To test our central
hypothesis, we hereby present a three-year research project composed of two specific aims. Aim 1 of our
proposal is dedicated to synthesizing new Pt(IV) complexes using the aforementioned scaffold and investigating
their photo-uncaging properties. In Aim 2, we aim to enhance the potential of our newly developed photo-
uncaging technology by validating and optimizing NIR-uncaging of drug molecules in vitro and in vivo. Successful
completion of Aim 1 will not only illustrate the scaffold's adaptability but also provide valuable information on the
photoreduction properties of the Pt(IV) complexes. The successful completion of Aim 2 could lead to the
development of a new NIR photo-uncaging technology with numerous noteworthy applications in different
domains, including drug delivery and phototherapy. The educational goal of this R15 proposal is to enhance
undergraduate student biomedical research at Kent State University (KSU). Based on the different background
of the two PIs, including bioinorganic chemistry and cell biology, we seek to establish a multidisciplinary research
program to support three undergraduate students and one graduate student at KSU every year.

Public health relevance
PROJECT NARRATIVE Photoinduced cleavage of chemical bonds is an efficient and noninvasive way for selective release and delivery of biochemically relevant compounds in vivo towards chemotherapeutic and diagnostic applications. Near- infrared (NIR) light is benign and penetrates deeper into tissues, which presents an efficient way to realize these goals. Towards this goal the proposed research will establish a new design of platinum-based framework toward NIR-uncaging of bioactive molecules.